Neuroinflammation in Wallerian Degeneration and Regeneration: Neutrophils Play a Primary Role as Phagocytes

Understanding the process of neural degeneration is important in order to understand the responses of the
nervous system to injury and disease. A common model used in such studies is the distal segment of the sciatic
nerve after nerve transection or crush. Following such a lesion, Wallerian degeneration occurs in which the distal
segment of the nerve fragments and degenerates, and the resulting axonal and myelin debris are cleared away.
Interestingly, while this process occurs rapidly in the peripheral nervous system (PNS), it is extremely slow in
the central nervous system (CNS), and, partly because of this, regeneration is generally ineffective in the brain
and spinal cord. It is widely believed that inflammatory macrophages (mφs) derived from blood-borne monocytes
are required for the phagocytosis of axonal and myelin debris. Immune cells enter injured tissue in response to
chemotactic cytokines or chemokines. A major population of monocytes infiltrates into the distal nerve after
axotomy in response to the chemokine CCL2, which acts on monocytes via the chemokine receptor CCR2. In
mice in which the gene for CCR2 is knocked out, CCR2+ monocytes do not enter the nerve. It was, therefore,
very surprising when we found that the clearance of both myelin and axonal protein is normal in Ccr2 knockout
mice. We subsequently found that an important reason for the normal clearance appears to be phagocytosis by
neutrophils, an immune cell not previously implicated in Wallerian degeneration. In fact, although neutrophil
actions in the CNS are beginning to be examined, for example in models of multiple sclerosis, there are almost
no studies on their actions in the PNS. Our preliminary evidence using the neutrophil-depleting antibody anti-
Ly6G suggests, but does not prove, that neutrophils directly phagocytose and metabolize myelin. We will
examine this hypothesis by examining the clearance of myelin proteins by western blotting before and after
neutrophil depletion and by co-labeling tissue with Oil Red O, a stain for myelin metabolites, and with cell type
specific neutrophils antibodies. We have shown that after axotomy two neutrophil attracting chemokines are
induced in the sciatic nerve, CXCL1 and CXCL2. To determine whether these chemokines and their receptor,
CXCR2, are involved in neutrophil infiltration into the nerve, we will use neutralizing antibodies, pharmacological
antagonists, and knockout mice. We will investigate also whether the involvement of neutrophils in Wallerian
degeneration is important for subsequent regeneration. “Wallerian-like” degeneration occurs in several
demyelinating neuropathies, and we will examine whether neutrophils play a role in this phenomenon. We will
use a mouse model for Guillain Barré syndrome based on our recent finding that neutrophils enter into the sciatic
nerve in this model. Following up on our unexpected findings of normal clearance of myelin in Ccr2 knockout
mice, our experiments will examine the role of neutrophils in Wallerian degeneration and in a demyelinating
disease. Given the known importance of Wallerian degeneration for nerve regeneration due to the removal of
myelin proteins, our studies will suggest ways of improving regeneration in the PNS and perhaps in the CNS.

Public health relevance
Project Narrative Since neural degeneration is an important component of the response to neural trauma and is a consequence of a number of neurological diseases, it is a major public health problem. We have reported the unexpected finding that a group of immune cells thought to be required for clearing debris from degenerating nerves is not required, and we present the first evidence that a quite different group of immune cells is required for this process. We will explore in depth the cells and receptors required for this clearance and therefore for nerve regeneration.